Evolutionary genetics of genotype-by-environment interactions for complex traits

PROJECT SUMMARY
A key question in my research is: why does diversity in quantitative traits persist, despite
evidence of selection that should eliminate this diversity? Environmental variation can generate
genetic tradeoffs both among and within populations, helping to maintain this genetic diversity. I
study the genetic mechanisms and architecture of these tradeoffs in nature. My recent research
has focused on two central goals: 1) developing approaches for finding the genetic basis of local
adaptation and 2) empirical testing of hypotheses about local adaptation and G×E. I propose
research to study genetic mechanisms of adaptation to environment using a model system that
is convenient for ecological experimentation, Arabidopsis thaliana. This work will test
hypotheses about the genetic architecture of adaptation to changing environments through
space and time, about how gene flow influences genetic architecture, and about the role of gene
expression plasticity in adaptation to variable environments. In all projects, our ability to conduct
ecologically realistic but controlled common garden experiments will provide information on
genetic variation in environmental responses (G×E) that can be used to interpret observational
data from nature. We will first study the genetic mechanisms of adaptation to temporally
changing environments. We will study how different populations of have adapted to hundreds of
generations of environmental change by sequencing genomes of museum specimens. Second,
we will study local adaptation along montane environmental gradients with different levels of
isolation to test how gene flow influences the architecture of local adaptation. This project will
collect populations from different geographic contexts and conduct experiments to characterize
the genetic basis of local adaptation and expression plasticity. My proposed work will make
important strides in testing how tradeoffs along complex environmental gradients influence
genetic diversity across the genome.

Public health relevance
PROJECT NARRATIVE Genetic variation can cause individuals to differ in how they respond to their environment, leaving some human individuals susceptible to particular complex diseases. By understanding the evolutionary forces causing genetic-environmental interactions we may better understand the genetic origins of complex disease. As technology advances, expanded personal environmental data will allow greater investigation of genetic-environmental interactions in human health, and the genetic signatures of environmental adaptation can be leveraged to make predictions and decisions for human health.